Data and Statistical Services Core

The Data and Statistical Services Core provides comprehensive data collection, processing, and analysis services for TREC investigators. These include instrument design, sample selection, mail and phone surveying, data entering, computerized data editing, analysis file creation, statistical analyses consultation, and computer programming. These services will be provided to investigators of the three large projects in the TREC, as well as to developmental project grantees and career development trainees. The Core director, Dr. Eileen Harwood, who will manage and direct the Core, has extensive experience in the area and also manages the Data Services Core of the University of Minnesota Comprehensive Cancer Center. Statistical expertise in the Core is particularly noteworthy in regard to the projects proposed for this TREC. Cutting edge statistical approaches to multilevel modeling and analyses of studies with group-randomized designs are an especially noteworthy skill of the Core staff that will be especially helpful to two of our three research projects. It is believed that this group will be an important asset to TREC investigators.